Mobile Diagnosis of Congenital Genetic Conditions: A Model for Screening and Surveillance in Low-Resource Settings

SUMMARY
Congenital anomalies represent an increasing burden of disease worldwide, accounting for millions of birth
defect-related disabilities with a disproportionate impact on Low to Middle Income Countries (LIMCs). Many
harbor genetic etiologies, for which no confirmatory diagnosis can be made due to the dearth of diagnostic
technologies in most LMICs. The inability to rapidly and accurately diagnose individuals that harbor a genetic
syndrome increases the risk of mortality and morbidity (as a number of manageable congenital anomalies may
be hidden, such as congenital heart defects or hearing infections) and prevents the accurate determination of
prevalence rates, critical for public health surveillance and intervention programs.
The first part (R21) of this project addresses these gaps using two synergistic mobile health intervention tools
to screen for syndromic conditions and specifically demonstrate that a specific diagnostic of Down syndrome
(expandable to all aneuploidies and those diseases resulting from copy number variants, point mutations and
insertions/deletions) can be performed with minimal resources, in the Democratic Republic of the Congo
(DRC).
Aim 1 will be to train and validate AI-guided smartphone-based technology to screen for syndromic
conditions, while Aim 2 will create low-cost, rapid initial genetic diagnostic capacity in the DRC.
In the expansion part of the proposal (R33), we will test whether the implementation of a registry measuring
health outcomes can be used as a scalable model for future newborn screening and health surveillance in a
low-resource setting. To this effect, Aim 3 will build infrastructure for birth defects detection, genetic
confirmation, competence building, and practice and outcomes surveillance in low-resource conditions
with two parallel sub-aims: Aim 3a will assess the feasibility of the diagnostic capacity on a large
population sample and provide a tool to measure specific health outcomes, while Aim 3b will establish a
small-scale and functional database/registry of morphological, genetic, and health outcomes data.
In limited resources settings, comprehensive systems to detect, refer, treat and surveil individuals with
congenital anomalies are non-existent. Our innovative technologies will address this gap, build local capacity of
diagnostic screening and of a data registry, allowing for early diagnosis and condition-specific care, likely to
lower morbidity and mortality of children with non-communicable syndromic conditions.

Public health relevance
Millions of individuals in Low-to-Middle-Income Countries are affected by birth defects, representing a major global Public Health burden. We propose innovative low-cost strategies for reducing the impact of birth defects, based on mobile, facial recognition software to screen for dysmorphic syndromes (including Down syndrome), coupled with practical genetic solutions for early diagnosis in the Democratic Republic of the Congo (DRC). Our partnership between Institut National de Recherche Biomédicale, a DRC national research institute, and Children's National Hospital in Washington, DC, will create the infrastructure of a birth defect Registry, allowing for future surveillance and intervention programs in low resource settings.